Statistical and Machine Learning Methods to Improve Dynamic Treatment Regimens Estimation Using Real World Data.

Project Summary/Abstract
Type 2 diabetes (T2D) is a global epidemic affecting approximately 462 million individuals world-wide. Cur-
rent medical treatment guidelines rely largely on data from randomized controlled trials (RCTs) that study average
effects, which is far from adequate for making individualized decisions for real world patients. This limitation is
even worse for discovering dynamic treatment regimens (DTRs) in a heterogeneous population where treatment
decisions are made over one or more stages of disease course. This limitation can be partially addressed by sup-
plementing RCT data with real world data (RWD), such as disease registries, prospective observational studies,
surveys and electronic health records, to improve medical decision making. Despite of the promise of combining
RWD and RCT, there are several signiﬁcant challenges in method and algorithm development. These include
lack of generalizability or practical utility for the ﬁndings from RCTs when applied to real world patients; bias due
to unobserved confounders; and concern about long-term side effects/risks. This proposal aims to address each
of these challenges. Speciﬁcally, in Aim 1, we address the generalizability issue by proposing a novel framework
that uses evidence from RWD to improve learning DTRs in the trials. The framework uses RWD to select infor-
mative tailoring features, balance population distributions and improve statistical efﬁciency through doubly robust
estimation. In Aim 2, to improve the practical utility of DTRs, we propose a robust method to ﬁrst infer individual
treatment choice/preference from RWD, then incorporate this estimated preference into learning DTRs using the
trial data. The resulting DTRs are not only statistically valid but also compatible with patient/clinician preference
in real world populations. In Aim 3, to lessen the bias due to hidden confounders in RWD, we propose joint
semiparametric models to combine the trial data with RWD; the models we propose allow different magnitudes
of treatment effect sizes and control for possible bias due to hidden confounders in RWD. In Aim 4, to address
the concern about long-term risks, we consider a general procedure for estimating DTRs that maximizes efﬁcacy
outcomes while ensuring that long-term side effects associated with the recommended DTRs remain below a
certain threshold. We then propose a novel simultaneous learning algorithm to estimate the optimal DTRs across
all stages. For all four aims, we will provide rigorous assumptions and theoretical justiﬁcations using tools from
concentration inequalities, statistical learning theory, empirical processes and semiparametric inference. We will
conduct extensive simulation studies to study the performance of the proposed approaches in a variety of set-
tings, and compare their performance with off-the-shelf methods. We will apply the proposed methods to estimate
DTRs for T2D using clinical trial data and RWD taken from electronic health records in Columbia University and
Ohio State University medical centers as well as Allof Us precision medicine study. Our methods and ﬁndings will
be publicized through software development; the software will receive frequent updates based on user feedback.

Public health relevance
Project Narrative This proposal aims to develop novel statistical methods and machine learning algorithms for use on real world data sets and clinical trial data in order to infer dynamic treatment regimens. The proposal will address im- portant challenges to the integration of real world data into estimation, such as differential distributions, real world treatment patterns, confounding bias and consideration of beneﬁt-risk tradeoff. The results from this proposal will complement the current knowledge base for individual patient care and will further accelerate the translation of clinical trial ﬁndings into practice.